EFFECT OF HYPERINSULINEMIA IN CEREBRAL VASCULAR PERMEABILITY

Examination of the effects of acute hyperinsulinemia on vascular permeability in normal men through plasma osmolarity, plasma osmotic pressure, plasma volume, transcapillary albumin escape, capillary permeability and extracellular fluid volume.